The Development of CSD peptides for the therapeutic treatment of post-acute sequelae of COVID-19 (PACS)

Abstract
Acute respiratory distress syndrome (ARDS) from SARS-CoV-2 infection activates many lung
remodeling pathways observed in Idiopathic Pulmonary Fibrosis (IPF) and reports indicate
that symptoms persist for 2 to 12 months or longer in approximately 33% of hospitalized
patients. To address this emerging health concern, this proposal aims to 1) develop a
translational model for post-acute COVID-19 sequelae (PACS) induced organ fibrosis and to
use this model to 2) rigorously assess efficacy of a potentially prophylactic, antifibrotic
therapeutic peptides patented and developed by Lung Therapeutics, Inc (LTI). A reduction of
Caveolin-1 expression is observed in human fibrotic tissues and histopathology revealed that
endogenous CAV-1 protein expression was significantly reduced in 10 unique fatal COVID
lungs. Furthermore, CAV-1 RNA was reduced in PACs tissue samples from which cells for
this model will be derived. The anti-fibrotic activity of LTI’s patented portfolio of Caveolin-1
scaffolding domain (CSD) peptides is conferred through the 7-amino acid sequence
FTTFTVT.
The 7-mer was formulated as an inhaled dry powder and is currently undergoing a
phase 1 safety, tolerability, and pharmacokinetic study (NCT04233814) as it demonstrated
the ability to reverse established fibrosis in multiple in vivo pre-clinical models of dermal,
cardiac, and pulmonary fibrosis (PF) and attenuates multiple pro-fibrotic signaling pathways
in vitro. However, given that a dose limit of 20mg was observed in this trial, and PACS has
been observed to effect other organs aside from the lung as well as systemic vasculature, a
more soluble, stable, XR, subcutaneous, injectable version of LTI-03, called LTI-2355. LTI-
2355 has demonstrated robust anti-inflammatory and antifibrotic effects in a variety of human
and rodent fibrosis models. Moreover, preliminary PK data on our depot, extended release
(XR) formulations indicate that it is stable and available in the lung following a single injection
at putative therapeutic dose levels out to 14 to 22 days. Given our experience with the IPF-
SCID mouse system, we hypothesize that robust lung fibrosis with possible development of
multi-organ fibrosis will develop following intravenous administration of live human pulmonary
cells from discarded COVID lung transplants (viral titer negative) into SCID mice. If
successfully established, we will not only test three putative extended-release (XR)
therapeutic peptides in this novel PACS model, but we will also publish the methods and
characteristics of the model, which may potentially become an important tool for testing
putative PACS interventional therapeutics. Taken together, we propose to establish a
translational mouse model of PACS, and to test three patented LTI-2355-XR formulations via
(SC) delivery and compare against efficacy of a control peptide and Nintedanib, the standard
of care for IPF, and a current candidate for PACS therapy (PINCER, NCT04856111). Pending
efficacious results (composite reduction in pro-inflammatory and pro-fibrotic indicators of at
least 40%, a lead candidate will be selected, and a Phase II SBIR will be filed to support
further clinical development (PK/PD, toxicology specific to the SC formulation, IND-supporting
work). This proposal caters to the aggregate strengths of the team including peptide
formulation, expertise in the biochemical assessment of translational mouse models of
pulmonary fibrosis, immunology, organ fibrosis, pharmacokinetics, and overall drug
development. Finally, this project has strong potential to yield a novel therapy for the treatment
of PACS.

Public health relevance
Narrative Acute SARS-CoV-2 infection invokes maladapted tissue remodeling leading to persistent pulmonary symptoms and re-hospitalization. To address this emerging public health concern, this proposal aims to 1) develop a translational model of post-acute sequalae of COVID-19 (PACS) induced organ fibrosis and to utilize this model to 2) rigorously assess efficacy of an anti-inflammatory and antifibrotic therapeutic patented and developed by Lung Therapeutics, Inc (LTI). Taken together, this project aims to develop a therapeutic intervention for hospitalized SARS-CoV-2 patients who are at high risk for developing PACS.